Training in Cardiovascular Research at the University of Hawaii

Abstract
This application for renewal of the Cardiovascular T32 training program at the University of Hawaii
draws on the strengths of our Center for Cardiovascular Research (CCR) and our established
graduate program in Cell and Molecular Biology. We also have maintained and enhanced an alliance
with the Cardiovascular Division at Stanford University Medical School to enrich the local academic
environment and increase the number of seasoned senior investigators available as mentors for our
trainees. In recent years our medical school has embarked on a new direction, emphasizing basic
investigation that has instilled new energy into our graduate programs. We have moved into a modern
campus on the shore of Honolulu and attracted nationally competitive investigators. Our
Cardiovascular Center has recruited or developed 6 independent investigators who have a principal
focus on cardiovascular investigation. In addition we have a group of UH faculty with established
research programs pertinent to cardiovascular science. We now have the critical mass of
investigators needed for a successful T32 program. During our first cycle of funding we were the only
T32 in the State. During both cycles we have had success in training under-represented minority
scientists and in helping our trainees to obtain independent grant funding. During the past cycle we
also saw the development of a joint T32 between the Cancer Center and USC as well as a K12
program in Tropical Medicine. We assisted both programs in their applications and they have helped
to augment our training efforts and the pool of young investigators at the School. We still have our
roots in our minority-serving, clinically-focused school, but are adding an important level of scientific
sophistication to serve our special location and multiethnic population. During the third cycle of
funding, described in this application, we will continue to place our best graduate students and
postdoctoral fellows in laboratories devoted to cardiovascular projects, and provide mentoring that will
help them succeed. They will benefit from an established curriculum, CCR core resources, and will
also be able to draw upon the Stanford Cardiovascular Division for world-class expertise and
research resources. We request support for three graduate students and three postdoctoral fellows
per year. We expect, on average, that the graduate students will be supported for no more than three
years and the postdocs for no more than two years before they either finish or obtain independent
funding. Thus we anticipate supporting approximately 7 individual postdoctoral fellows and 5 graduate
students during the 5 years of this program. Our goal is to train our next generation of cardiovascular
investigators, with special attention to the priorities of our local population.

Public health relevance
T32 Narrative This application is for renewal of a training program that will provide support for predoctoral and postdoctoral trainees performing cardiovascular research at the University of Hawaii.